ACTG 364--COMPARISON OF THE VIROLOGIC EFFICACY OF NELFINAVIR AND/OR DMP 266

This is a randomized, partially double-blind trial for ACTG 302-303 participants who were originally randomized to d4T monotherapy or new combination nucleoside therapy and who remain on their originally assigned treatment at the time of enrollment into this rollover protocol.